Assessment of MODS and Personalized Exposures of Antibiotics

ABSTRACT
Multiple organ dysfunction syndrome (MODS) affects as many 57% of critically ill children, with mortality rates
as high 67% in those infected. The long-term goal of this proposal, Antibiotics in MODS: PersonaLizing
Exposures (AMPLE), is to leverage the well-established infrastructure from our PARADIGM study
(R01HD095976) to identify optimal antibiotic dosing strategies for this highly understudied, high-risk
population. Infection is a common occurrence in children with MODS, either as an inciting insult or as a result
of a new, nosocomial infection. However, management of children with MODS and infection is complicated by
the development of immune paralysis (IP), which has deleterious effects on immune function. Unfortunately,
antibiotic management strategies and how they should be modified as a function of host immune status are
key knowledge gaps in pediatric MODS. Timely attainment of target antibiotic concentrations is a crucially
important, modifiable intervention to increase survival in these children, yet we currently have limited data on
antibiotic pharmacokinetics (PK) in children with MODS with which to develop personalized dosing strategies.
We will quantify antibiotic PK in 400 subjects enrolled in the PARADIGM study, an ongoing, NIHfunded, 22-
center, prospective study of the epidemiology and risk factors for IP in 1,400 children with MODS.
The objectives of this application are to use samples and clinical data from PARADIGM subjects to
characterize the variability of concentrations for the antibiotics most commonly used in pediatric MODS; to
investigate the relationships between antibiotic target attainment and outcomes in pediatric MODS with and
without IP; and to develop model-based dosing approaches that rapidly achieve and maintain target antibiotic
concentrations. The central hypothesis of this proposal is that precision, PK-driven antibiotic dosing
strategies can be developed that adequately account for organ dysfunction and immune function in children
with MODS. We propose to pursue the following AIMs: 1) To create and evaluate sophisticated population PK
models for the 6 most commonly used antibiotics in pediatric MODS. 2) To define antibiotic target windows
outside of which children with MODS (with and without immunoparalysis) who are being treated for infection
are at increased risk for death and prolonged organ failure. 3) To use simulations to identify dosing strategies
that achieve and maintain antibiotic concentrations within defined therapeutic windows. The proposed studies
will answer the following key questions about the pharmacology of pediatric MODS: 1) What proportion of
children are under- or over- exposed using the current standard dosing approaches?, 2) How does MODS
impact antibiotic PK and outcomes in children?, 3) How does IP impact necessary target concentrations in
pediatric MODS? This research is expected to be significant as it will result in first-of-its kind data that are a
crucial and a necessary step toward developing Precision Antibiotic Dosing strategies for children with MODS.

Public health relevance
PROJECT NARRATIVE Multiple organ dysfunction syndrome (MODS) affects as many 57% of critically ill children, with mortality rates as high 67% among those infected. Infectious outcomes are affected by the host immune response and timely, effective antibiotic strategies; however the modification of antibiotic management strategies as a function of both MODS and host immune paralysis (IP) are key knowledge gaps in pediatric MODS. By leveraging the PARADIGM study infrastructure (R01HD095976), the objectives of this application are to characterize the variability of concentrations for the antibiotics most commonly used in pediatric MODS; to investigate the relationships between antibiotic target attainment and outcomes in pediatric MODS with and without IP; to develop model-based dosing approaches that rapidly achieve and maintain target antibiotic concentrations.